Real-time Prediction of Adverse Outcomes After Surgery

The goal of this K23 application is to provide Dr. Bishara with the necessary research experience and
time to establish himself as a primary investigator focused on designing and implementing machine learning
(ML) and artificial intelligence in the perioperative setting. The career development activities in this application
include early intensive course work in ML and statistics focused on improving model development and causal
inference techniques. Then coursework focuses on clinical trial training, grantsmanship, responsible conduct of
research, and culminates in a course studying implementation science and algorithmic human-robot interaction.
Augmenting this training are project-specific tutorials with experts to improve the models proposed in this
application with a focus on real-time prediction of perioperative acute kidney injury (AKI) and describing the risk
landscape of perioperative AKI. To achieve these goals, Dr. Bishara has assembled a team of experts and
mentors in the areas of data science, AKI, ML, and statistics. Dr. Atul Butte, his primary mentor, is an expert in
data science and ML and has trained nearly 100 post-doctoral fellows, undergraduate and graduate students,
and staff. Dr. Kathleen Liu is a thought leader in the field of AKI with an active research program focused on AKI
and critical care clinical trials. She has mentored numerous junior faculty, including previous NIH K23 awardees.
Dr. Romain Pirracchio is an expert in biostatistics and ML in acute care. He has collaborations with Berkeley and
the FDA and over 100 publications in the realm. These three mentors and the impressive team of advisors will
guide Dr. Bishara to complete the project described below and to grow into an independent investigator.
There has been a recent surge in the published literature on ML in medicine, and studies have shown
patient care improves when provider expertise is augmented by ML. Unfortunately, implementing published ML
models to inform clinical care is not trivial, as many obstacles exist. This application focuses on exploring and
overcoming those obstacles by implementing specific models in the perioperative setting. Dr. Bishara has
developed novel ML visualization technology that allows for improved interactions between providers and
models, which provide predictions and recommendations to those providers. This technology also allows for
improved regular monitoring and interpretation of the model to assure sustained accuracy and reliability. He will
apply this new technology to predict perioperative AKI in real-time, building upon models he has developed.
Postoperative AKI is a major public health problem affecting up to 47% of patients and is consistently associated
with adverse outcomes, including, major adverse cardiovascular events (MACE), increased healthcare costs,
and death. Randomized controlled trials show that implementation of kidney-protective strategies prevents AKI
for high-risk patients. Evidence suggests these strategies are underutilized as risk of AKI is often underestimated
in the perioperative setting. Dr. Bishara hypothesizes his ML models will identify those patients who will most
benefit from timely kidney protective interventions at the time when preventative strategies can be initiated.

Public health relevance
Despite consensus on a clear set of effective kidney-protective strategies to reduce the risk of acute kidney injury (AKI), these treatments are often underutilized during surgery because perioperative risk of AKI is underestimated; as a result, AKI affects 18-47% of surgical patients and is associated with adverse outcomes including chronic kidney disease, major adverse cardiovascular events (MACE), increased healthcare costs, and death. This problem provides an excellent opportunity for machine learning (ML) because ML has already been shown to predict AKI better than clinicians, but these models have not yet been implemented in the perioperative period because of multiple technical and logistical barriers that we have developed technology to overcome. We propose implementing and updating innovative models that predict and alert clinicians of impending perioperative AKI during surgery when preventative treatments can be provided and, in the process, use these models to better understand the landscape of risk and design new treatments for AKI.